Determinants of Cell State Reprogramming

Determinants of cell state reprogramming
PROJECT SUMMARY
Forced expression of transcription factors (TFs) can reprogram cell state. The discovery of direct reprogramming
has been a catalyst for our understanding of the molecular and genetic drivers of cell state. However, despite its
successes, only a handful of successful reprogramming cocktails have been identified, the conversion process
is often inefficient, and the mechanistic reasons for reprogramming failure are often unclear. Thus, a key obstacle
to further progress is our incomplete understanding of the determinants and mechanisms of cell state conversion.
Our long term goal is to understand the genetic and molecular basis of cell state, which has important implications
for synthetic control of cell state for regenerative medicine. Towards this goal, the objective of this proposal is to
elucidate the molecular and cellular determinants of cell state reprogramming. Specifically, we seek to address
several fundamental gaps in knowledge on cell state reprogramming with three central research directions: 1)
Epigenetic determinants of cellular reprogramming, 2) Genetic and temporal determinants of cellular
differentiation, and 3) Initial cell state determinants on reprogramming. This scope is made possible by our
innovative platform that couples multifactorial, pooled perturbation with multidimensional readouts for each cell
spanning perturbations (induced TFs), mechanisms (epigenome), and phenotypes (transcriptome). By tracing
thousands of individual cells on their path to reprogramming across a multitude of distinct perturbations, our high
throughput functional experiments will reveal insights and suggest mechanisms for the determinants of
reprogramming. Our rationale is that learning these fundamental rules of reprogramming will improve our
understanding of the molecular basis of cell state and enable improved approaches to manipulate it.

Public health relevance
Determinants of cell state reprogramming PROJECT NARRATIVE The proposed research is relevant to public health because understanding the molecular and cellular drivers of cell state is ultimately expected to advance the capability to engineer specific cell types for regenerative medicine. The project is relevant to the part of NIH's mission to accelerate basic biomedical research that increases our understanding of biological processes and lays the foundation for advances to ultimately improve human health.